Training in Molecular and translational Cell Dynamics

Abstract
This is a multidisciplinary training program under the Graduate Research Training Initiative for Student
Enhancement mechanism at the University of Toledo (UT), and involves ten participating programs. The
overarching goal of the program is to train a significant number of diverse professionals with the skills
and leadership required for careers in biomedical research. This goal is aligned with the missions of the
NIH and the University of Toledo Strategic Plan. The program will broaden the pipeline of candidates and
utilize effective multiprong mechanisms to recruit trainees from traditionally underserved communities. To
achieve this objective, partnerships have been established with eight minority-serving undergraduate
institutions with NIGMS-supported research training programs, including the ReBUILDetroit program, as
well as with disability-serving programs. Scholars will participate in a summer bridge program prior to
matriculation and receive intensive training and mentorship to form networks, enhance social integration
and perseverance. A multifaceted innovative and evidence-based program will be implemented in
supportive environments to increase trainees success rates, sharpen leadership, scientific rigor, and
communication skills. Training will leverage the resources and intellectual environment of the UT Medical
Campus to expose trainees to translational research in health disparities and biomarker discovery to
better-equip them for careers with significant impacts on the unique health-related research needs of
underserved communities and the nation. In conjunction with the Ph.D. degrees, scholars will receive
training in bioinformatics and earn a Certificate in Biomarker and Bioinformatics to position them well for
careers in the forefront of biomedicine. Through various activities, the program will guide and engage the
trainees in identifying and pursuing a range of potential career options in basic sciences. At the end of the
five-year grant period, this program will produce forty-eight skillful biomedical researchers who will
enhance the diversity of the biomedical workforce and positively impact the local economy. The program
will have wider impacts by enriching the educational curricula and the cultural environment at UT, by
engaging the local communities through the numerous targeted activities of our trainees, and by
contributing to maintaining the competitiveness of the U.S. in the global economy

Public health relevance
Narrative This innovative evidence-based training program will produce a number of highly-trained biomedical researchers from underserved communities who will contribute to eliminating the nation’s health disparities